NIDDK Multidisciplinary Predoctoral Training in Discovery and Translational Research

PROJECT SUMMARY/ABSTRACT
This is a renewal application to build on multidisciplinary predoctoral training in discovery and translational
research at Mayo Clinic with a focus on Digestive Diseases and Gastroenterology including the inter-
related fields of Diabetes/Metabolic Disease and Kidney Disease (DDK). The overarching objective
remains to develop a diverse pool of well-trained biomedical career scientists with the experience and
skillsets to become leaders as the next generation of DDK researchers. Two senior and accomplished
Mayo scientists with an extensive background in graduate education and mentoring will continue to co-
direct this program centered upon four Mechanism-Centric Research Communities in 1) Bioengineering
and Biophysical Analysis, 2) Cell-to-Cell Communication, 3) Genomic Regulation, and 4) Intracellular
Signaling, with 27 interdisciplinary faculty members and $20 M in NIH funding. This core DDK faculty
provides a robust infrastructure with a successful history of training career scientists in discovery-based
and translational biomedical research. These laboratories offer a rich mentoring and training environment
that is uniquely tailored to the individual student while also promoting collective experiences across multiple
disciplines. The Specific Aims focus on fundamental aspects of reproducible and rigorous biomedical
research aligned with NIDDK priorities. 1) Offer a solid foundation in hypothesis-based experimentation,
research design, rigor, quantitative analysis of datasets, with objective interpretation of results. 2) Foster
broad multidisciplinary understanding combined with critical independent thinking skills to identify
outstanding biomedical questions and initiate new approaches to advance the field. 3) Develop effective
oral and written communication skills across diverse audiences. 4) Promote ethical conduct in biomedical
research and team skills that facilitate collaborative research while promoting an inclusive work
environment. 5) Provide the background to identify and effectively transition into productive DDK
investigators. The program encourages synergistic interactions between basic science departments and
NIDDK-funded Centers in Digestive Disease, Translational PKD, and Pathobiology of the Enteric System
at Mayo Clinic. Participation in national meetings and various programmatic activities, like journal clubs,
seminar and works-in-progress series, career development events, annual retreat, plus Mayo-wide
symposium and poster session are encouraged. These activities synergize with three related postdoctoral
programs at Mayo in Digestive Diseases, Diabetes and Metabolism, and Kidney Disease, while offering a
complete continuum from summer undergraduate research experiences through PhD and postdoctoral
training. Requirements for completion of the PhD degree conform to those of Mayo Clinic Graduate School
of Biomedical Sciences, including a first author publication. With a strong pool of 198 qualified eligible
graduate students, the proposal requests expanded support for 6 predoctoral trainees per year.

Public health relevance
PROJECT NARRATIVE Success in the pursuit of new treatments for diabetes, digestive, and kidney diseases require developing the next generation of career biomedical scientists. This Mayo Predoctoral Training Program is focused upon this important societal goal.